Probing the Function of Long Non-Coding RNAs in Differentiation

PROJECT SUMMARY
The over-arching focus of my research program has been to identify spatial and temporal aspects of regulating
gene expression. Our recent emphasis has incorporated mouse embryonic stem cells (ESCs) as a model
system to understand gene dynamics and various aspects of gene expression, including the role of long non-
coding RNAs (lncRNAs). LncRNAs represent an exciting class of tens of thousands of RNAs among which
very few have thus far been functionally characterized. A number of lncRNAs have been shown to exhibit cell-
type specific expression, localization to subcellular compartments, and association with human diseases
suggesting that they have critical roles in many cellular processes. The long-term goal of this project is to
identify the mechanism of action of several lncRNAs identified in an RNA-seq screen that have roles in
pluripotency and/or differentiation, and potentially represent different functional classes, Such analysis will
provide insight into how these lncRNAs regulate differentiation through their impacts on gene expression
and/or nuclear organization. Here, we propose to characterize an exciting nuclear-retained lncRNA, Platr4, that
is highly expressed in pluripotent ESCs and is significantly down-regulated upon ESC differentiation. We will
examine the impact of Platr4 knockout and over-expression on global gene expression in ESCs. In addition,
Platr4 expression will be examined throughout embryonic development and the impact of Platr4 knockout will
be examined in developing mouse embryos to identify critical points of function and candidate genes and
pathways regulated by Platr4 in early mouse development. Based upon preliminary studies, the role of Platr4
in mesodermal and endodermal lineage commitment will be an immediate focus of investigation. The functional
interactions of Platr4 will be identified by an RNA-tagging strategy combined with RNA-seq (ChIRP-seq) to
identify genomic interactions of Platr4, and with mass spectrometry (ChIRP-MS) in order to identify proteins
interacting with Platr4. Together, the proposed studies will provide important insights into the functional role of
Platr4 in lineage commitment and differentiation, and will provide new insights as to how regulatory signals
instructed by a long non-coding RNA can impact differentiation and potentially reprogramming.

Public health relevance
PROJECT NARRATIVE This study will determine the function of a long non-coding RNA (lncRNA), Platr4, in regulating differentiation of mouse embryonic stem cells. Revealing the role of Platr4 in this basic fundamental process will provide new insights as to how regulatory signals instructed by a non-coding RNA can impact differentiation. Findings from this study will provide important insights that will influence our understanding of differentiation and reprogramming and thus will be critical to advance our approaches to develop treatment strategies for a wide range of diseases.